Adaptation and Pilot of a Peer-Facilitated Self-Help Plus Stress Management Intervention for Breast Cancer Patients in Viet Nam

PROJECT SUMMARY
I am an Assistant Research Scientist in the Department of Social and Behavioral Sciences at the New York
University School of Global Public Health (NYU GPH). My career goal is to engage in research and practice that
improves the mental health of marginalized populations globally. My academic training included applied
mathematics (BS, ’05), health policy and management (MPH, ’08), community health sciences (PhD, ’14), and
global mental health (postdoctoral fellowships, ’17 and ’20). I have also received training in mixed-methods and
community-based participatory research. Although I have strong analytical skills in evaluating mental health
interventions, I would now like to develop skills to support the implementation of mental health interventions that
are integrated with the treatment of other health conditions—particularly: cancer. This pivot will require an
additional set of knowledge and skills. Accordingly, my goal in this K01 award is to obtain tailored training and
mentorship in four key areas critical in becoming an independent international research scientist with a focus on
global cancer control and prevention. I have assembled an experienced, international, multidisciplinary team of
mentors who are committed to my career development. The mentoring committee will be co-led by two
distinguished scholars in implementation science and health services research: Dr. Donna Shelley (NYU GPH)
and Dr. Minh Van Hoang (Hanoi University of Public Health [HUPH]). My co-mentors include two experts in
global mental health research and practice—Dr. Lawrence H. Yang (NYU GPH) and Dr. Wietse A. Tol (University
of Copenhagen)—and two experts in cancer control and prevention—Dr. Ophira Ginsburg (NYU Perlmutter
Cancer Center) and Dr. Huong Tran (Hanoi Medical University, Viet Nam National Cancer Institute). The career
development activities are designed to leverage the wide range of mentors and activities at NYU and to facilitate
the knowledge exchange between NYU and HUPH throughout my alternating residences between the U.S. and
Viet Nam. My research plan is to adapt and pilot an enhanced stress management intervention for breast cancer
patients in Viet Nam. First, I will conduct qualitative research to assess the acceptability and appropriateness of
implementing the Self-Help Plus (SH+) program, with an additional peer support component, to help breast
cancer patients manage their distress. The findings from this step will help identify the potential modifications
needed. Second, I will convene a working group to select and implement the adaptations, including the additional
Peer support component (P). Finally, I will pilot the adapted, peer-facilitated SH+P intervention to evaluate its
feasibility. Upon successful completion of the training and research activities, I will be prepared to develop an
R01 proposal to test the implementation and effectiveness of the adapted intervention in reducing psychological
distress among breast cancer patients in Viet Nam. Findings can ultimately inform the development of evidence-
based, culturally-adapted psychosocial interventions for cancer patients in many low- and middle-income
countries as well as for different racial/ethnic groups in the U.S.

Public health relevance
PROJECT NARRATIVE We aim to adapt and pilot a guided self-help stress management program from the World Health Organization and to incorporate peer cancer survivors in providing psychosocial support to breast cancer patients in Viet Nam. We seek to demonstrate the feasibility of the culturally and contextually adapted intervention in reducing the psychological distress associated with cancer diagnosis and treatment, to ultimately improve cancer patients’ health outcomes. Successful completion of the project begins to fill the gaps in the lack of culturally appropriate evidence-based mental health interventions for cancer patients in many low- and middle-income countries, and in many racial/ethnic groups in the U.S.